Experimental Resources for Studies of Tenocyte Differentiation and Cell Fate Diversity

Project Summary/Abstract
Tendons connect muscles to bones and transmit the force generated by muscle contraction. Because of
their unique position, the tendons are subject to significant shear and compression forces resulting in
frequent tendon damage and tears. Tendons are also highly susceptive to development of degenerative
conditions and because of slow and limited healing capacity tendon and ligament conditions account to
more than 50% of visits to orthopedic clinics and present a major burden to individuals and society. A
relative increase in tendon and ligament conditions in recent years led to a significant increase in the
number of studies and research grants associated with tendons. This research is largely focused on
clinical applications in tendons and it was recently recognized at NIAMS and within the research
community that the basic research in tendons remained too limited and the absence of basic
information resources is a major impediment to progress in tendon research. This understanding was
indeed emphasized in the conclusions of a Tendon related conference sponsored by IAMS a few years
ago. However, because of internal NIAMS policies, this realization was not followed by an RFA or NIH
driven research consortium to address these experimental needs.
Our labs has been at the forefront of identifying new tendon genes and developing research tools for
tendon research in mouse and sharing them with the tendon community. We therefore decided to
propose a project focused and the development of experimental resources and the rapid sharing of
these resorces. The first aim in this project is therefore to use RNAseq in various developmental and
mature stages and by comparison identify tendon differentiation stages and develop for each of these
stages a comprehensive and authoritative list of genes with distinctive expression in tendons. In addition
we will define a prorotypic short least of genes whose expression define these stages and can be used as
success criteria for the programing of stem/progenitor cells to the tendon cell fate stages. In the second
specific aim we will perform single cell RNAseq transcriptome assays to identify potential diversity of
sub-specialized tenocytes in tendons. One cell type we will focus on in this aim is the epitenon, a critical
part of the tendons that receives very limited research attention to date. Finally, the 3rd specific aim is to
develop new mouse models for tendon research including additional cre lines with more specific
targeted activity in tenocytes and associated cell types. And to develop additional mouse mutants to
identify genes regulating the tendon cell fate. Since this project is defined as a resource development
grant we will further focus on the rapid dissemination of all these data resources and mouse lines to
support a more rapid progress in tendon and ligament research.

Public health relevance
Project Narrative Tendon and ligaments injury and degeneration account considerable burden to affected individuals and public health. In this project we will develop essential and missing resources, necessary for significant progress in studies of these tissues including descriptions of gene expression in tendons and new mouse models